Impact of the Initial Influenza Exposure on the Quality, Magnitude, Breadth, Potency and Durability of Influenza Immunity

PROJECT SUMMARY ABSTRACT
A more universal vaccine against influenza virus infection is urgently needed. However, a major obstacle
limiting more effective and durable vaccines against influenza infection stem from the rapidly shifting nature of
viral immune dominant epitopes. Further confounding this obstacle are functional differences in the
immunological responsiveness to vaccination and susceptibility of individuals to natural infection primed by
prior exposure to influenza antigens. This type of immunological imprinting likely explains the wide discordance
in effectiveness of current seasonal influenza vaccines. Considering the near ubiquitous exposure of
individuals to influenza virus, together with the wide variability in clinical symptoms from asymptomatic to
severe infection and increasingly widespread use of seasonal immunization, immunological imprinting to
influenza virus is likely initiated during infancy with the first exposure to natural infection or immunization.
Importantly, critical knowledge gaps remain regarding how individuals respond to primary influenza exposure in
early life, in the context of natural infection or vaccination, and how a lack of pre-existing immunity effects
within-host influenza viral diversity. It is also unclear how this first exposure to influenza impacts the
subsequent immunological responsiveness to antigenically identical, similar or discordant influenza epitopes.
For infants, the impact of vertically transferred maternal immunity, or that acquired postnatally through
breastfeeding, on the quality of ensuing influenza specific immune responses remain unclear. To fill these
knowledge gaps, ongoing recruitment of a maternal-infant cohort at Cincinnati Children’s Hospital will be
expanded, along with parallel efforts in Mexico City. Both sites have ongoing surveillance providing additional
cases of symptomatic primary infection. With the proposed enrollment of more than 2000 pregnant women, our
two-site cohort is ideally suited for the proposed studies given our established infrastructure of weekly nasal
swabs and symptom reporting, scheduled blood collection to detect asymptomatic and symptomatic influenza,
maternal and cord blood and milk sample analyses and detailed evaluations of susceptibility and
immunological responses to influenza infection and vaccination in mothers and infants. Our overall hypothesis
is that primary influenza exposure in early life impacts the magnitude, durability and breadth of immunological
memory to an evolving range of influenza virus antigens and this initial imprint will have a profound effect on
subsequent influenza exposures. A team of investigators with complementary expertise in pediatric infectious
diseases, epidemiology, maternal-infant cohorts, human B and T cell immunology and influenza virology have
been assembled to address our hypothesis by investigating the immunological response of infants to primary
influenza virus natural infection compared with immunization (Aim 1), compare the immunological response
against an initial exposure to influenza virus via natural infection or immunization in infants (Aim 2), and
investigating the impact of pre-existing influenza immunity on virus genetic diversity within individuals (Aim 3).

Public health relevance
PROJECT NARRATIVE Defining the Impact of Initial Influenza Exposure on Immunity in Infants Establishment of a maternal-infant cohort in Cincinnati and Mexico City to detect influenza infection and vaccination will provide the framework to improve our understanding of the immunological responses to the initial infant influenza exposure, be it infection or vaccine, and how that initial exposure imprints the infant’s response to subsequent exposures. The information gained from the Influenza IMPRINT Cohort and the planned analyses will provide the knowledge needed to develop an effective universal influenza vaccine. Our instructive maternal-infant cohort will investigate unique features of how individuals immunologically respond to natural infection compared with vaccination, and the potential impact of vertically transferred maternal immunity. Longitudinal evaluation of these individuals will establish how prior influenza exposure impacts susceptibility and the immune response to infection by genetically identical, similar or discordant influenza virus strains that draws a blueprint for more universal influenza vaccines strategies.